TRIAL OF IMPLANTABLE CARDIAC DEFIBRILLATORS VS ANTIARRHYTHMIC DRUG THERAPY

The purpose of this protocol is to evaluate the efficacy of cardiac defibrillators versus antiarrhythmic drug therapy (amiodarone and sotalol) in treating survivors of ventricular tachycardia or fibrillation.